PILOT-FEASIBILITY

PROJECT SUMMARY (Pilot/Feasibility Core)
The objective of the BBDC Pilot/Feasibility Core (PFC) is to build on our experience in years 1-5 to
continue a solicitation, review, funding, and reporting of pilot studies from both inside and outside the BBDC
investigator community for research projects that leverage the BBDC infrastructure and data. The ultimate
goal for these pilot projects is to advance the mission of the BBDC, especially as it relates to clinical trial
readiness in Osteogenesis Imperfecta as well as more broadly on rare bone diseases. In years 1-5, two pilots
were proposed in the prior application and both pilot studies have been completed. These produced data that
informed the design of the longitudinal study of OI (Project 1) specifically in the area of anxiety and pain
interference in OI), and that led to two publications on the topic of PROMIS and patient engagement in
research. In addition, we also developed a process for soliciting, reviewing, and funding of new pilot studies.
This resulted in submission of 17 proposals from both inside and outside of the BBDC. We ultimately funded
on project on collagen X biomarker measurement which supported the scientific premise of the current Project
3 proposal on longitudinal biomarker study of growth in OI. We propose to extend and improve on this pilot
mechanism by broadly soliciting applications from a wide community of OI and bone health researchers. We
will continue a review process that is in the NIH format while emphasizing projects that support the BBDC
mission, leverage the BBDC infrastructure and data, and advance clinical trial readiness.